Bridging the gap of endogenous nitro-conjugated linoleic acid formation and signaling

PROJECT SUMMARY
Myocardial ischemia-reperfusion injury is a multifactorial event characterized by oxidative stress and
mitochondrial damage. Interrupted blood supply establishes ischemia, and restoration of flow introduces a
second wave of damage caused by uncontrolled reduction of oxygen (i.e., superoxide). Superoxide and nitric
oxide produced by nitric oxide synthase in the myocardium initiates both lipid peroxidation and nitration in cell
membranes. Lipid peroxidation mechanisms and consequences have been the focus of many studies, yet efforts
are not matched for lipid nitration. Mechanistically, lipid nitration proceeds by the addition of nitrogen dioxide, a
product of NO and oxygen radical reactions, to conjugated fatty acids. Complex lipids (i.e., triglycerides and
phospholipids) are recognized as the main substrates for lipid nitration. However, their chemical complexity
amplifies the challenges of analytical characterization. Nitrated conjugated linoleic acid (NO2-CLA) is an anti-
inflammatory fatty acid that forms during cardiac IR injury. NO2-CLA formation was first established in a model
of coronary artery ligation, and later work identified the mitochondria as a source of the nitrated species. Due to
its electrophilic character, NO2-CLA reversibly modifies cysteines in target proteins to modulate signaling
cascades. The impacts of NO2-CLA-mediated signaling have been evaluated in inflammatory, autoimmune, and
viral infection preclinical models. Through these studies, covalent targets were identified, including Nf-kB, Keap1,
and STING. Complementary to preclinical efforts, in a small clinical study of cardiac arrest, plasma levels of NO2-
CLA correlated with patient survival. Despite this evidence, the mechanism of NO2-CLA formation in IR remains
to be established, as well as the target protective signaling pathways. Given that phospholipids represent a major
class of lipids in the myocardium and accumulate CLA, it is hypothesized that during cardiac IR injury, CLA
esterified to phospholipids acts as a scavenger for nitration radicals, forming NO2-CLA that is released by
phospholipases to initiate protective signaling cascades by modification of protein thiol targets. This hypothesis
will be tested by the following two Aims: Aim 1: Establish that CLA esterified to phospholipids is a target for lipid
nitration. Aim 2: Determine the protein targets that are modified by NO2-CLA during IR injury. Using cardiac H9c2
cells and isolated hearts subject to IR conditions, we will evaluate lipid nitration products, covalent targets, and
protection endpoints. Mass spectrometry and novel bio-orthogonal labeling will serve as the experimental pillars,
as they bring analytical value, physiological relevance, and innovation to this project. Overall, the proposed work
will be the first to demonstrate the role of myocardial phospholipid nitration in establishing levels of NO2-CLA for
the activation of protective and anti-inflammatory signaling pathways during IR injury.

Public health relevance
RELEVANCE TO PUBLIC HEALTH This project aims to demonstrate that CLA acts as a biological relay through the formation of protective and anti- inflammatory NO2-CLA during cardiac IR injury. Successful completion may lead to nutritional interventions to limit damage and preserve cardiac function during IR.